EFFICACY/SAFETY OF 24 &48 WEEKS OF DE-ESCALATING REGIMAN OF ROFERON-A

This study will investigate equivalence of six monthas and twelve months of treatment with interferon alfa-2 on maintenance of biochemical response twenty-four weeks after stopping treatment.